Inflammasome-gasdermin axis in bullous pemphigoid

Project Summary
Bullous pemphigoid (BP) is an autoimmune subepidermal blistering disease characterized by autoantibodies
and an inflammatory infiltrate. BP autoantibodies recognize two hemidesmosomal proteins, BP180 and BP230.
Anti-BP180 IgG autoantibodies fix complement and are pathogenic. NC16A, an extracellular domain of BP180,
is the primary target of pathogenic autoantibodies. Elevated proinflammatory cytokines TNF-α and IL-1β are
present in blister fluids and sera of BP patients. However, the roles of these critical inflammatory mediators and
how they are up-regulated in BP remain unknown. Our preliminary results showed that subepidermal blister
formation induced by pathogenic antibodies is dependent on IL-1β, a cytokine whose secretion is uniquely
dependent upon the inflammasome signaling pathway. We further show that specific inflammasome mutant
mice resist the pathology of BP. Therefore, the objective of this proposal is to study the role of
inflammasomes in BP using our BP mouse models. Our central hypothesis for this proposal is that BP
antibodies trigger an inflammasome cascade starting with the NLRP3 inflammasome (Aim 1), that activates
caspase-1 and caspase-14 (Aim 3), culminating in the activation of gasdermin A, which forms the IL-1β
secretion pore (Aim 2). The overall goal of this project is to increase our understanding of the innate immunity
of BP and how it relates to the functions of innate immune system players in inflammation and autoimmunity.
Our preliminary data are promising and strongly support our working hypothesis. Since this proposal integrates
both disease mechanistic and preclinical studies, the findings are expected to have a significant impact on the
treatment of patients with BP and other skin inflammatory disorders. This grant will also have broader
implications to the basic biology of inflammation in the skin. Gasdermin A is a new innate immune gene known
to form a pore in the cell membrane, yet its true function in vivo remains a mystery. Because IL-1β is a potent
and central inflammatory mediator in skin inflammatory disease, these studies with gasdermin A will have
broad impact and will reveal hitherto unimagined aspects of the basic biology of IL-1β secretion from
keratinocytes.

Public health relevance
Project Narrative Bullous pemphigoid is a potentially fatal autoimmune blistering disease. We will study the autoantibody-mediated inflammatory responses in the skin blistering disease bullous pemphigoid using in vitro and in vivo model systems. Findings from these studies may help identify new targets and develop more effective therapies for bullous pemphigoid and other autoimmune and inflammatory diseases.